Enhanced Research and Experiential Learning for Undergraduates Using X-ray Diffraction

PROJECT SUMMARY/ABSTRACT:
Salish Kootenai College (SKC), on the Flathead Indian Reservation in Montana, is a well-
established and vital Tribal College and University (TCU) that primarily serves
undergraduates from indigenous and rural communities. The Department of Life
Sciences at SKC was the first TCU to offer a Bachelor’s in Cell Biology and is currently
the only tribal college to offer a Bachelor’s in Environmental Health Sciences. These
degree tracks are complemented by a molecular- and chemistry-intensive research
program centered in the One Health philosophy. The research program infrastructure was
initially built around environmental assessment of heavy metals; however, much of the
specialized equipment is becoming antiquated and not well suited to the interests of the
program’s biomedically-focused students. Therefore, the vision of the program is to
revitalize its infrastructure through the acquisition of a key piece of equipment: a Bruker
D6 Phaser X-Ray Diffractometer (XRD) along with accessory stages to characterize
small, air-sensitive samples and samples undergoing phase transitions with temperature
variation. This powerful benchtop XRD requires relatively minimal maintenance over a
long lifespan and is user friendly for undergraduates; thus, providing a platform for diverse
experiential learning and research opportunities to study the atomistic structure of
compounds which is currently not possible at SKC. The more detailed structural analysis
provided by XRD will synergize with existing equipment that still functions to provide basic
functional group information of compounds in a number of academic courses and
educational activities. Similarly, the new avenues of research discovery and/or
collaboration will significantly help the program achieve its immediate and long-term
goals; while, simultaneously developing undergraduates with a deeper understanding of
structure for promising careers in advanced biomedical fields such as pharmaceutical
science, nanomaterials, and forensic-based structural analysis.

Public health relevance
PROJECT NARRATIVE: The Life Sciences at Salish Kootenai College (SKC) is expanding its capacity to study the atomistic structure of known and synthesized materials in the context of its biomedical- based programs. This expansion will provide new research and educational opportunities for those undergraduates that are particularly interested in the areas of pharmaceuticals, environmental health sciences, and forensics.